Immuno-cardiology 2025 Symposium

This proposal seeks support for a symposium, Immuno-Cardiology 2025. Immunology is of great importance to cardiovascular research since inflammation and fibrosis are indicators of both heart failure progression and myocardial remodeling, topics at the core of NHLBI’s research mission. The involvement of the immune system in health and disease is currently an area of intense interest in the field, requiring innovative, interdisciplinary research to realize the potential for transforming the landscape of cardiovascular medicine. Cardiovascular disease is the leading cause of death in the United States, and improving our understanding of the role of inflammation in heart disease will improve patient outcomes.
We hosted a highly successful inaugural conference on the topic of Immuno-cardiology in September 2023 that featured recent advances in the basic science and clinical relevance of dysregulated immune activation and fibrosis in response to cardiac injury, presented by an unprecedented cross-section of established and emerging leaders in their areas of expertise. The conference attracted a capacity audience of over 100 participants. Our long-term goal is to facilitate collaborations and growth in this important field.
Specific Aims of the symposium: 1) Build on the momentum of the 2023 Symposium, bringing together various expertise in the field to continue exploration of synergies and opportunities for cross-fertilization and translation in this fast-moving field; 2) Integrate findings from related organ systems (kidney, lung and liver); 3) Foster relationships to encourage new collaborations; 4) Attract interest and participation from the next generation of scientists who will transform this interdisciplinary field.
The meeting is unique in that it will bring together academic, clinical and pharmaceutical-based scientists, include researchers looking at relevant organ systems other than the heart, and showcase the work of young investigators. NIH support for the symposium will specifically provide travel funding to promote participation by early career scientists, graduate students and postdoctoral fellows.

Public health relevance
This proposal seeks support for Immuno-Cardiology 2025, a research symposium that will highlight new discoveries in the growing field of immuno-cardiology and explore therapeutic approaches that limit cardiac inflammation and associated fibrosis. The meeting is unique in that it will bring together academic, clinical and pharmaceutical-based scientists, will include researchers looking at relevant organ systems other than the heart, and will showcase the work of young investigators. NIH support for the symposium will specifically provide travel funding to promote participation by early career scientists, graduate students and postdoctoral fellows.